Web-Based ACTIVE Memory Training Intervention for Older Adults

DESCRIPTION (provided by applicant): This proposal responds to PA-11-124 Translational Research to Help Older Adults Maintain Their Health and Independence in the Community (R21) and seeks support to test a web-based version of the evidence-based ACTIVE (Advanced Cognitive Training for Independent and Vital Elderly) memory training intervention for use by community organizations to promote memory health and fitness among the elderly. Memory loss is a major public health problem among community-living older adults, and is often associated with loss of independence, need for formal care, and institutionalization. Although there is growing evidence that small-group, trainer-led, paper-and-pencil based classes used in ACTIVE lead to significant cognitive gains and some improvement in everyday function, they offer few practice opportunities outside of class time, are limited in their ability to reach the growing population of older adults, and are not easily disseminated due to high costs of administration. The proposed use of online, interactive technology for this cognitive training is conceived as superior to the limited approach used in the original ACTIVE trial and in most previous training research. We propose to field test an online program called ACTIVE Memory Works (AMW) to help older adult users increase performance and monitor changes in memory and cognition and assess their effects on daily functional activities. The web- based AMW experimental intervention will: greatly reduce administrative costs compared with the paper-and- pencil form by incorporating automated data collection and analysis; provide automated scoring and reporting; increase engagement with context-sensitive coaching based on individual progress; and provide opportunities to evaluate a larger sample of categories and exemplars for memory tasks; and increase user-directed practice. This yields an overall design with the following key features: 1) a baseline assessment and randomization to a 10-session experimental intervention group, a 10-session experimental intervention plus 4-session booster group, or to a wait-list control condition, and 2) an immediate post-test and 6-month follow-up test. The use of the online format will make possible the widespread dissemination necessary to begin to make a difference in the lives of older adults interested in monitoring and maintaining their memory performance, cognitive vitality, and quality of life in the face of age-related memory impairments and begin to reduce the costs of institutionalization. Several community organizations are ready and able to participate.

Public health relevance
PUBLIC HEALTH RELEVANCE: Memory loss is a major public health problem among community-living older adults, and is often associated with loss of independence, need for formal care, and institutionalization. Although there is growing evidence that small-group, trainer-led, paper-and-pencil based classes can lead to significant memory gains and some improvement in everyday function, they offer few practice opportunities outside of class time, are limited in their ability to reach the growing population of older adults, and are not easily disseminated due to the high costs of administration. This project proposes a web-based, interactive translation of the evidence-based Advanced Cognitive Training for Independent and Vital Elderly (ACTIVE) memory training intervention that can be disseminated to and by community organizations to help older adults interested in monitoring and maintaining their memory skills, cognitive vitality, and quality of life in the face of age-related memory impairment and help reduce the need for institutionalization. __SpecificAimsTextDelimiter__ Specific Aims This proposal responds to PA-11-124 Translational Research to Help Older Adults Maintain Their Health and Independence in the Community (R21) and seeks support to test a web-based version of the evidence-based Advanced Cognitive Training for Independent and Vital Elderly (ACTIVE) memory training intervention for use by community organizations to promote memory health and fitness among the elderly. Specifically, this study will field test an online program called ACTIVE Memory Works (AMW) to help older adult users increase and monitor changes in memory and cognition and assess their effects on daily functional activities. Memory loss is a major public health problem among community-living older adults, and is often associated with loss of independence, need for formal care, and institutionalization. Although there is growing evidence that small-group, trainer-led, paper-and-pencil based classes used in ACTIVE lead to significant cognitive gains and some improvement in everyday function, they offer few practice opportunities outside of class time, are limited in their ability to reach the growing population of older adults, and are not easily disseminated due to high costs of administration. The proposed use of online, interactive technology for this training is conceived as superior to the limited approach used in the original ACTIVE trial and in most previous training research. The web-based AMW experimental intervention will: greatly reduce administrative costs compared with the paper-and-pencil form by incorporating automated data collection and analysis; provide automated scoring and reporting; increase engagement with context sensitive coaching based on individual progress; provide opportunities to evaluate a larger sample of categories and exemplars for memory tasks; and increase user- directed practice. This yields an overall design with the following key features: 1) baseline assessment and randomization to a 10-session experimental intervention group, a 10-session experimental intervention plus 4- session booster group, or to a wait-list control condition, and 2) an immediate post-test and 6-month follow-up test. The use of the online format will make possible the widespread dissemination necessary to begin to make a difference in the lives of older adults interested in monitoring and maintaining their memory performance, cognitive vitality, and quality of life in the face of age-related memory impairments and begin to reduce the costs of institutionalization. Several community organizations will assist in the proposed translation of the ACTIVE program for use in larger provider and community-based networks. The Specific Aims are: Aim 1: To assess the efficacy of the AMW web-based training program in enhancing memory abilities and everyday function in a community sample of healthy older adults Aim 2: To determine if booster training further enhances the efficacy of the AMW training program Aim 3: To longitudinally assess the maintenance of training gains on memory abilities and everyday function over a 6-month period In summary, AMW is designed to meet a variety of specific memory training needs for community-residing, well individuals of advancing age, and to encourage individual behavior change with regard to everyday memory performance, perceived memory difficulties, and global aspects of day-to-day functioning.